Advanced Development of Vaccine Candidates for Antibiotic Resistant Bacteria

To support the advanced development of a candidate vaccine for resistant bacteria. This contract may support formulation and manufacture of the individual vaccine components, as well as stability testing, nonclinical immunogenicity and efficacy testing in animal models, IND enabling GLP toxicology, submission of an IND and clinical safety and efficacy evaluation. This project includes a Phase 2 clinical trial.